The convergence of stress and sex on Abeta and tau metabolism and pathology

Psychological stress is one of the largest environmental risk factors for Alzheimer’s disease (AD). Women
are more prone to stress and are at higher risk of AD than men. Our preliminary data demonstrate a sex-
dependent effect of stress on both Aβ and tau. In two distinct models of acute stress, restraint stress and
predatory olfactory stress, only females have a rapid and prolonged increase in brain interstitial fluid (ISF) Aβ
levels in the hippocampus, whereas Aβ in males does not change. The increase in females is blocked by
inhibiting the CRF receptor (CRF-R). Interestingly, CRF-Rs signal differently in females and males. During
stress in females, CRF-Rs normally activate PKA/ERK whereas in males CRF-Rs are withdrawn from the
plasma membrane by β-arrestin, so there is significantly less CRF signaling in males. Consistent with this
mechanism, our preliminary data demonstrates β-arrestin1 knockout males have restored CRF-Rs on the cell
surface, and when stressed ISF Aβ levels increase nearly identically to females. Our data also demonstrate a
similar sexual dimorphic response to stress for tau. In response to stress, ISF tau levels increase in both males
and females, but females have a 4-fold greater increase than males. The literature demonstrates that
corticosterone, a main stress protein throughout the body, can increase tau levels. We propose that the
disparate tau responses in each sex are primarily driven by two mechanisms: 1) differential CRF-R signaling
that drives the difference between the sexes, similar to A and 2) a common mechanism in both sexes that is
driven by corticosterone to increase tau levels similarly in males and females. While previous studies have
implicated CRF and β-arrestin in AD, these will be some of the first studies studying these pathways in AD in
the setting of stress.
We hypothesize that stress causes sex-dependent increases on Aβ and tau that are mediated by
CRF-R/β-arrestin signaling, as well as sex-independent effects on tau driven by corticosterone. We
propose to determine the signaling pathways that are activated by acute stress in males and females to
regulate Aβ and tau levels differently. We will also chronically stress mice that have altered CRF or
corticosterone (cort) signaling or lack β-arrestin expression to determine effects on behavior and pathology.
Our premise is that determining the cellular pathways that differ between the sexes could identify risks of
developing AD and lead to therapeutics to specifically modulate the stress response in AD based on sex.

Public health relevance
Stress is a risk factor for developing Alzheimer’s disease. In the United States, 70% of Alzheimer’s patients are women, who are also more prone to stress-related disorders than men. We propose that increased stress in women is just one factor that increases their risk of AD. This proposal will determine the cellular mechanisms that differentially regulate Aβ and tau in females and males following stress.